A clinical platform for ultrasound-augmented laparoscopy

SUMMARY
The overall objective of this project is to develop a clinical system that fuses laparoscopic video and
laparoscopic ultrasound for enhanced visualization and navigation of laparoscopic procedures. Real-
time video acquired using a laparoscope remains the primary visualization and guidance modality in
over 14 million procedures performed per year globally, but it shows the operating surgeon organ
surfaces only. Laparoscopic ultrasound can show internal structures, but is often displayed on a
separate screen, leaving the surgeon to perform a mental integration of the 2 modalities. This task is
inefficient, subjective, and variable with expertise. Introduction of a needle in the surgical field for
ablative procedures further increases the surgeon's cognitive load by needing to register multiple
sources of information for understanding three-dimensional spatial relationships and for maintaining
hand-eye coordination. The proposed real-time data fusion, which we refer to as augmented reality
(AR), presents complementary information to the operating team in an intuitive way. Research,
development, and clinical translation efforts preceding this proposed project have demonstrated the
technical feasibility and clinical utility of the proposed AR visualization and navigation. The team has
successfully developed research prototypes and used the most recent prototype in 11 human cases at 2
different surgical centers. This proposal is borne out of the real-world lessons from our clinical
translation experience toward building a clinical system. The major areas of improvement include
reducing system complexity and size and improving reliability and clinical viability. Children's National
Hospital and Terason will collaborate to develop custom specialized laparoscopic ultrasound
transducers and offer AR as a well-integrated advanced application on a commercial ultrasound
platform. The specific aims for this project are to 1) develop custom tracked laparoscopic ultrasound
transducers, 2) develop a commercial-grade ultrasound system with integrated tracking and AR
technologies, and 3) conduct preclinical evaluation of the developed system. Our scientific premise is
that comprehensive intraoperative visualization of normal and pathological anatomy and navigated
guidance of ablation needles will improve the precision, safety, and efficiency of prevailing laparoscopic
procedures, and expand their utilization. The proposed academic-industrial partnership is designed
such that these benefits are realized through the development of a clinical system ready for routine use
in the operating rooms worldwide.

Public health relevance
NARRATIVE Minimally invasive surgeons are limited to a surface view of the intraoperative field as provided by real- time video. By adding ultrasound, this project will develop a new augmented reality visualization technology that will allow surgeons to see hidden structures such as tumors and blood vessels below the organ surfaces. The anticipated clinical benefits of augmented reality visualization are shorten procedure times, fewer complications, reduced blood loss, and expanded use of minimally invasive surgeries.